CRISPR-mediated Chemical Genetics Define Transcription Factor Gene Networks and Mechanisms of Control

ABSTRACT
Sequence-specific transcription factors are critical mediators of cellular adaptation in response to both
extracellular and intracellular cues. These rapidly changing transcriptional programs facilitate everything from
cell fate decisions to stress responses, and the disruption of transcription factor function and/or expression is
associated with disease states including developmental disorders, neurologic disorders, and cancer. While it is
clear that the appropriate regulation of gene expression is critical for normal cellular function, historically, our
ability to understand how sequence-specific transcription factors rapidly and specifically alter transcriptional
programs has been limited by a toolbox of very slow genetic and knockdown strategies that take days to weeks
before transcription factor activity can be assayed. Therefore, while direct transcriptional effects occur within
minutes to hours, these models take days to establish resulting in the detection of secondary and/or
compensatory transcriptional changes that often mask the direct/immediate effects of transcription factor
disruption. In order to overcome these technical limitations, we use CRISPR-mediated genome editing to
introduce degron tags into endogenous transcription factor loci. This chemical-genetic approach results in rapid
transcription factor degradation (minutes to hours) following PROTAC treatment, and effectively collapses the
timeframe for assaying transcriptional changes, chromatin states, and genome-wide transcription factor
occupancy from days to hours. We complement these studies with proteomics-based approaches to identify
associated complexes and cooperating transcription factors, and are beginning to incorporate single cell and
single molecule imaging approaches to interrogate heterogeneity within transcriptional responses. Combined,
these approaches are allowing us to address fundamental questions in the transcription field including how
transcription factors are influenced by and exert influence over the chromatin landscape, how multiple sequence-
specific transcription factors cooperate to regulate gene expression, and how enhancer activity influences
promoter activation.

Public health relevance
PROJECT NARRATIVE Transcription factors are proteins that control how and when genes are turned on or expressed. Proper control of gene expression is critical for normal cell function, and transcription factor disruption is frequently associated with human disease. We have taken a new approach to study transcription factors in which these proteins are rapidly degraded by a small molecule, and we will build upon these studies to define the mechanism of transcriptional control by these critical proteins.